Administrative Core

PROJECT SUMMARY/ABSTRACT – ADMINISTRATIVE CORE
The primary objective of the Administrative Core is to ensure the effective integration and interaction of the
scientists and other personnel working on the Projects and Scientific Cores that comprise this PPG. First, the
Core establishes the scientific priorities and directions of the research through regular meetings of the PPG’s
Executive Committee. Second, the Core is responsible for administering the day-to-day activities of the PPG,
including monitoring all budgets, submission of progress reports, and adherence to regulatory requirements
associated with our research. Third, the Core coordinates the many modes of communication among PPG
investigators, including regular meetings, work-in-progress seminars, and interactions with our Internal
Advisory Committee, that ensure our cohesive research program. Likewise, the Core supports visits to New
York by members of our External Advisory Committee, and key consultants, to meet with PPG faculty and
trainees and review the progress of our research. Fourth, the Core maintains a creative PPG website to foster
communication not only among PPG investigators, but also with the scientific community and general public at
large. Such communication includes resource and data sharing and the dissemination of vast amounts of
genome-wide gene expression and chromatin data as rapidly as possible as well as enabling the free
download of novel PPG software designed to analyze complex datasets. Fifth, the Core fosters several
additional outreach efforts to patient advocacy and community organizations. Sixth, the Core, through the
Executive Committee, works to ensure the successful career paths of numerous students and postdoctoral
trainees. We expect several individual R and K grants and NRSAs to be generated by the PPG's research.
Such career development focuses in particular on the recruitment and retention of women and of scientists
from under-represented groups; we are very proud of our track record in this regard. Seventh, the Core is
responsible, in collaboration with our various training programs, to ensure the safe and ethical conduct of
research with the highest rigor. Joining together effectively to form a unified research team is key to the
success of this large undertaking, and we are confident in our continued ability to accomplish this goal.